Mechanisms and Therapeutic Targeting of Motor Neuron Death in SMA

Spinal muscular atrophy (SMA) is a neurodegenerative disease characterized by motor neuron loss and skeletal
muscle atrophy. SMA is caused by ubiquitous deficiency in the SMN protein and is the leading genetic cause of
infant mortality. To date, most SMA therapeutic approaches have focused on increasing SMN expression and
SMN-­inducing therapies have recently been approved for SMA. However, these therapies alone do not provide
a cure or SMA nd not all patients respond to treatment. Therefore, it remains essential to understand the
underlying mechanisms of SMA and identify SMN-­independent therapeutic approaches that can enhance the
benefit of SMN-­inducing strategies through combinatorial treatment. In this context, motor neuron death is an
irreversible pathogenic hallmark of SMA. Therefore, preventing motor neuron degeneration has fundamental
clinical implications for SMA therapy and could extend the window of opportunity for SMN-­inducing therapies to
exert their effect. However, this is hindered by limited knowledge of the death pathway and availability of
druggable-­targets for halting this process. This project aims to address these outstanding issues by investigating
the mechanisms underlying the initiation and execution of motor neuron degeneration in SMA as well as validate
the therapeutic potential of pharmacologically targeting this pathway in mouse models of the disease. The
premise of our proposed work is that the neurodegenerative pathway of SMA motor neurons represents a target-­
rich domain for the discovery of disease-­modifying pharmacological approaches that are SMN-­independent and
suited for combinatorial treatment of SMA. Building on our published and preliminary studies, we will characterize
the upstream mechanisms driving motor neuron death in SMA based on our hypothesis that SMN deficiency
triggers a p38MAPK/p53-­dependent neurodegenerative pathway (Aim 1). To broaden the range of candidate
targets for developing SMN-­independent neuroprotective approaches for SMA, we will determine the execution
mechanisms of motor neuron death through the identification and functional characterization of the downstream
effectors of p53-­dependent neurodegeneration in SMA (Aim 2). Lastly, we will leverage on the availability of a
highly selective, brain permeable inhibitor to test the hypothesis that p38MAPK activation is a shared pathogenic
mechanism associated with motor neuron death across mouse models of SMA with varying disease severity
whose inhibition is a viable therapeutic approach (Aim 3). We will also evaluate whether pharmacological
inhibition of p38MAPK enables enhanced synaptic rewiring by preserving SMA motor neurons in a paradigm of
combinatorial treatment with SMN upregulation. Successful accomplishment of our objectives has the potential
to provide key insights into the mechanisms of motor neuron death in SMA, identify new disease markers and
candidate targets to halt the neurodegenerative process, and establish pharmacological approaches for
neuroprotection to be used in combinatorial treatment of the disease with SMN-­inducing therapies.

Public health relevance
Breakthrough SMN- inducing therapies have recently been approved by FDA for the treatment of SMA. However, they do not provide a cure and therapeutic approaches that address unmet needs of SMA patients by enhancing the clinical benefit of SMN- inducing therapies through combinatorial treatment are highly sought after. To address this issue, our project aims to elucidate the mechanisms underlying the initiation and execution of motor neuron degeneration in SMA as well as establish the therapeutic potential of SMN-independent, pharmacological targeting of this pathway for neuroprotection.